STRIVE: Short-Term Research in Immunology and Virology Experience

Project Summary
Physician scientists and surgeon scientists comprise a vital component of the biomedical research workforce
yet statistics indicate a shrinking physician scientist workforce, lack of diversity and reduced pipeline of medical
students engaging in basic/translational research. The overall goal of this training program is to expand,
diversify and strengthen the physician and surgeon scientist pipeline that will become the next generation of
immunology and virology trained physician scientists across a breadth of medical specialties. Global infectious
pathogens creating current and future pandemics, novel immunotherapeutics with expanding applications in
cancer and other diseases, increasing prevalence of allergic and autoimmune disease, and exciting
innovations in transplantation necessitate more immunology and virology trained physician and surgeon
scientists. Each year a highly diverse class of over 200 medical students (≥50% female, 26%
underrepresented in medicine) matriculate into the Ohio State University (OSU) College of Medicine (COM).
STRIVE T35 will leverage the OSUCOM medical student talent and diversity and the infrastructure of the COM
Office of Physician Scientist Education and Training (PSET) to recruit medical students to engage in short-term
immunology and virology research training during the summer between Med I and Med II. The OSU Short-
Term Research in Immunology and Virology Experience (STRIVE) will provide a 12 week summer research
experience including mentored research, didactics, participation in seminars and conferences, clinical
experiences and career development. Medical students will gain knowledge, skills, and abilities in 4 domains: 1)
Autoimmune disease, 2) Immune Oncology, 3) Virology and Microbial Immunity and 4) Transplant
Immunology. The faculty preceptors are experienced NIH-funded collaborative investigators with outstanding
training track records including success in inspiring and training medical students. STRIVE innovations include:
1) pre- T35 training preparation of a mini research proposal and development of individualized training goals
and plans 2) rigor and reproducibility lab-based training complemented by didactics, 3) a new short course in
Responsible Conduct of Research led by an ethicist, 4) focused clinical experiences to integrate immunology
and virology learning with clinical correlations in the 4 domains, 5) participation in seminars, conferences and
workshops to highlight cutting edge immunology and virology research and to gain broad exposure to leaders
in the field, 6) career development activities and 7) community building and networking with trainees in PSET
programs. STRIVE has well defined metrics and a robust program evaluation plan that will leverage OSU and
COM trainee tracking tools and program evaluation experts in addition to external review by a diverse and
expert external advisory committee. This new T35 program offers an unparalleled experience for highly
talented OSU medical students at a formative stage to broaden their career support network and to experience
the rewards and impact of immunology and virology related physician and surgeon scientist careers.

Public health relevance
Project Narrative The goal of the OSU STRIVE: Short-Term Research in Virology and Immunology Experience is to strengthen the pipeline of Immunology and Virology trained physician and surgeon scientists by providing mentorship, rigorous hands-on training and didactics, clinical correlative experiences, and career development activities at an early stage of medical training. The training program elements are designed to inspire future physician scientists to engage in discovery that will impact infectious disease, autoimmunity, organ transplantation, and cancer.